The transcriptional, regulatory, and spatially defined changes from mid to late gestation in a non-human primate model

Project Summary
Preterm birth is associated with decreased nephron endowment resulting in increased risk of chronic kidney
disease and end-stage kidney disease. Human nephrogenesis is completed prior to birth at 32-36 weeks
gestation. The majority of nephrons are formed through the poorly understood process, lateral branch
nephrogenesis (LBN). Nephron acquisition by LBN is unique to primates and occurs after 22 weeks gestation in
the human. During LBN, an elongating, non-branching ureteric bud (UB) tip induces nephron development with
each nephron directly connected to the ureteric stalk. In contrast, mice do not undergo LBN. Instead, mice
generate nephrons exclusively through branch phase nephrogenesis (BpN) wherein the UB undergoes
branching morphogenesis with each branch generating approximately two nephrons. The rhesus macaque is
the only known model that undergoes LBN like the human and is thus the sole model in which to define signaling
pathways controlling LBN. The central hypothesis is that the cell composition and spatial cell-cell signaling in the
LBN niche are distinct from BpN and negatively altered by preterm birth. The long-term goals are to leverage the
molecular mechanisms enabling LBN to develop strategies to maintain and/or extend LBN-supporting signaling
pathways in preterm infants. The objective of this proposal is to identify the progressive compositional, regulatory,
and spatially defined signaling environments in mid to late-gestation primate nephrogenesis. This will enable the
development of novel approaches to maintain or extend the LBN process postnatally in preterm infants. The
rationale is that the unique rhesus tissues already available and to be obtained through this proposal provide the
optimal resources to define critical cellular and signaling changes that occur during human kidney development
at single-cell and spatial resolution. The first aim is to determine compositional signaling pathway shifts and
regulatory relationships from mid to late-gestation primate kidneys. Single-cell multimodal transcription and
ATAC-seq analyses will be performed from replicate rhesus fetal kidneys in conjunction with powerful new
integrative regulatory prediction analyses. The second aim will be to elucidate spatially defined differences in
WNT signaling in mid to late-gestation primate kidneys. A key benefit of using rhesus tissue for these mechanistic
studies is that the tissue will be handled and fixed through a consistent protocol, thus minimizing variation in
RNA degradation that may falsely result in differences between gestational periods. Spatial expression of key
genes within the WNT pathway, including WNT ligands, receptors, inhibitors, and targets will be determined in
mid to late-gestation kidneys by RNAScope Hiplex assay and again validated in high-quality human archival
tissues to ensure conservation. Expected outcomes include a comprehensive cellular and transcriptional atlas
of primate kidney nephrogenesis determination of cell-cell signaling and spatial interactions that drive primate
nephron endowment.

Public health relevance
Project Narrative Human nephrogenesis is complete by 34-36 weeks gestation, with 60% of nephrons forming during the third trimester. Infants born preterm must continue nephrogenesis postnatally, but this process is negatively impacted in the neonatal environment, resulting in low nephron number and subsequent increased risk of chronic kidney disease and end-stage kidney disease later in life. This proposal forms the foundation for discovering targetable mechanistic pathways to maintain or extend normal nephrogenesis postnatally, a critical step toward improving kidney outcomes in infants born preterm.